Dissecting and targeting tumor-TME crosstalk to forestall acquired KRASG12C inhibitor resistance in NSCLC.

PROJECT SUMMARY/ABSTRACT
Oncogenic KRASG12C (KG12C) mutations underpin the development of ~14% of non-squamous non-small cell lung
cancer (NSCLC) and account for ~10,000 deaths annually in the U.S. The development of potent, selective and
clinically active covalent inhibitors of the KG12C oncoprotein represents one of the most exciting recent advances
in the field of targeted cancer therapy, yet strategies to circumvent the development of adaptive resistance and
improve the durability of individual responses to KG12C inhibitors are urgently needed in order to transform clinical
outcomes for patients. The role of crosstalk between tumor cells and the tumor microenvironment (TME) in the
development of acquired KG12C inhibitor resistance in NSCLC has not been systematically examined to date,
despite evidence that in more than 50% of cases no genomic resistance mechanisms can be identified at the
time of radiological progression. Furthermore, key mediators of TME remodeling and immune escape in
response to KG12C inhibitor therapy remain poorly defined and therapeutic strategies that target the adverse TME
in order to prevent, delay or overcome KG12C inhibitor adaptation/acquired resistance have not been established.
Finally, the impact of major co-occurring genomic alterations in STK11/LKB1 and TP53 and that shape the
immune contexture of KRAS-mutant NSCLC– on non-genetic mechanisms of acquired KG12C inhibitor resistance
is not known. Based on our preliminary findings and previous work we hypothesize that: 1. Remodeling of the
tumor microenvironment and immune escape can promote non-tumor cell autonomous adaptation/acquired
resistance to KG12C inhibitors; 2. Targeting STAT3 signaling with TTI-101 can forestall and possibly overcome
non-genetic acquired resistance to KG12C inhibitors through effects on tumor cells and/or the TME. In Aim 1, we
will determine the contribution of TME remodeling and immune escape to acquired KG12C inhibitor resistance in
NSCLC, using immune competent models of KG12C NSCLC that recapitulate its co-mutational complexity. We will
further interrogate the role of master mediators of TME adaptive remodeling with initial focus on STAT3 and we
will validate key findings using paired biopsies from patients with metastatic KG12C-mutant NSCLC that were
treated with sotorasib as part of standard of care. In Aim 2, we will evaluate the anti-tumor efficacy and TME-
modifying effects of STAT3 inhibition with TTI-101 in combination with direct KG12C inhibitors in immune-
competent models of KG12C NSCLC. Clinical significance: This work will yield fresh insights into non-genetic
mechanisms of acquired resistance to KG12C inhibitors that rely on tumor-TME crosstalk and will facilitate the
development of novel therapeutic strategies that tackle the adverse TME in order to maximize long-term clinical
benefit from KG12C inhibitors.

Public health relevance
PROJECT NARRATIVE This proposal will characterize non-tumor cell-autonomous mechanisms of acquired resistance to KRASG12C inhibitors in KRASG12C-mutant NSCLC using immune-competent animal models and clinical specimens and will evaluate the anti-tumor efficacy and immune-modulatory effects of combined KRASG12C and STAT3 inhibition.